Development and evaluation of a physical activity intervention for obese people with HIV in rural South Africa.

ABSTRACT
People living with HIV (PWH) living in the global south on modern first-line antiretroviral therapy (ART)
experience significant increases in body mass index (BMI). Obesity contributes to adverse health outcomes,
including cardiovascular disease, diabetes, and hypertension. Interventions that promote physical activity (PA)
are a particularly compelling strategy to address obesity and reduce the risk of cardiometabolic disease (CMD),
but remain relatively untested, and are not part of most regional HIV treatment guidelines. The scientific goal
of this K43 project is to develop and pilot-test a wearable-based PA intervention to reduce obesity and improve
CMD among PWH and obesity on dolutegravir (DTG)-based ART in rural South Africa. I am a postdoctoral fellow
with a PhD in Exercise Science and training in exercise physiology and HIV epidemiology leading to 15
publications (13 first-authored). My long-term career goal is to become a global expert in the development of
low-cost and locally-contextualised interventions to promote PA among PWH in low-resource settings. To realise
this goal, I will gain further training in 1) data science methods to measure PA using wearable devices 2) PA
behavioural intervention development, and 3) the conduct and evaluation of clinical trials to promote PA and
improve CMD outcomes in PWH. I will do so with mentorship from a team of world-class experts in these areas,
didactic training, and conduct of the following specific aims: To establish patterns of PA and sedentary
behaviour among PWH and obesity on DTG-based ART to inform the development of a PA intervention
(Aim 1). I will use accelerometers to assess PA indices and sedentary behaviour among 50 obese PWH on DTG-
based ART in rural South Africa. Our primary outcomes of interest will be mean steps/day, mean daily energy
expenditure, mean metabolic equivalents (METs)/day and sedentary behaviour. To develop a PA intervention
for obese adults living with HIV on DTG-based ART in a rural setting (Aim 2). I will use mixed methods to
refine an existing PA promotion intervention for PWH by combining information gleaned from Aim 1, results from
focus group discussions with Aim 1 participants and clinic nurses, data from a systematic review on PA among
PWH that I am leading, and expert opinion. To assess the feasibility, acceptability and preliminary efficacy
of a PA intervention to promote PA among obese PWH on DTG-based ART in a rural setting (Aim 3), I will
randomize 80 obese PWH on DTG-based ART in a ratio of 1:1: to standard of care (including information on
benefits of PA for health), or the contextualised, wearable PA intervention, derived in Aim 2. Primary outcomes
will be feasibility and acceptability. Secondary outcomes will be change in PA patterns and CMD markers, quality
of life and mental health. Completing these aims will lead to development of a contextualized PA intervention to
reduce CMD risk among PWH in South Africa and provide requisite data for an R01 application I will submit in
year 4 of the application to transition to research independence.

Public health relevance
PROJECT NARRATIVE High obesity rates increasingly contribute to cardiometabolic disease risk in people with HIV. This project addresses this public health issue by assessing physical activity patterns and developing a physical activity intervention to reduce cardiometabolic risks in obese individuals with HIV. If successful, this project is expected to lead to a novel intervention that could benefit people living with HIV and obesity in rural settings in South Africa and beyond.